Administrative

The purpose of this core is to create and implement administrative and leadership mechanisms that will foster effective interactions among the CMCR investigators and institutions to ensure a productive research effort. It is also responsible for overall organization, management, decision making, periodic evaluations, data sharing and involvement of institutional resources. The objectives of the Administrative Core are to: * Administer the budget; coordinate travel and purchasing. * Establish and organize an Internal Advisory Committee and an External Scientific Advisory Group. * Facilitate collaboration between the various Scientific Cores and Projects within the * Columbia CMCR. * Facilitate collaboration between this and other CMCRs. * Organize an annual retreat. * Coordinate patent applications. * Administer the Pilot program (see Core B for details). * Maintain the Consortium website

Public health relevance
A large scale radiological event could result in mass casualties from multiple types of radiation exposures, and there is thus a need for rapid, high-throughput biodosimetry to Identify those who most require treatment. The Administrative Core will provide support for research of high-throughput approaches to be useful for partial body, low dose rate, internal emitter, and neutron exposures, and also for potentially identifying individuals with particular sensitivities to radiation.